Modeling seizures in patients with focal epilepsy

Abstract
With an estimated annual cost of $12.5 billion in the United States, epilepsy affects approximately 3.4 million
Americans and carries a lifetime risk of around 3%. The most common form of epilepsy is focal in nature,
meaning seizures arise from a restricted part of the brain. It remains a significant challenge to predict who will
respond well to treatment despite modern technology and research, largely due to the heterogeneity of focal
epilepsy. Existing statistical methods to analyze seizure data do not appropriately address the within- and
between-individual variation in epileptic seizures over time.
We propose to leverage our access to the Human Epilepsy Project (HEP1 and HEP2), an observational study
of 450 patients with focal epilepsy that tracked seizures longitudinally, and our statistical and clinical expertise
to develop novel dynamic prediction models for seizure frequency over time. The daily seizure data from HEP
show (1) subgroups of individuals with different seizure trajectories and (2) clumping of seizures, in which a
patient is more likely to experience subsequent seizures following a seizure episode. Dynamic prediction
models have been used successfully in other clinical areas besides epilepsy, but they do not allow for
subgroups of trajectories. Similarly, clumping of events has been handled with the Hawkes process in
association models where a homogenous population is assumed. Instead, we seek to predict occurrence of
events and understand covariate effects on processes where subgroups of trajectories exist. We hypothesize
that accounting for subgroups of individual trajectories and clumping of seizures will provide more accurate
and precise prediction of seizure outcomes.
We plan to develop novel models for prediction of seizure events through the following aims: (i) Develop a
Bayesian nonparametric models for dynamic personalized prediction of seizures over time. We will use the
HEP1 dataset to predict longitudinal seizure count and occurrence that allows for subgroups of trajectories and
will evaluate the methods using HEP2 data, (ii) Develop a novel Dirichlet Process Mixture Hawkes process
model for personalized prediction of recurrent event data that will allow for subgroups and clumping of events;
and will compare to existing approaches to handle clumping, and (iii) Develop an R package and a shiny
application to implement and illustrate the novel methods. The expected outcomes of this work are both
clinically and statistically significant: a) a shiny application tool to obtain tailored predictions of longitudinal
seizure trajectory based on seizure history, treatment and other clinically relevant covariates that will help
patients and clinicians identify optimal treatment earlier in the personalized course of the patient’s disease; and
b) the new methods will be relevant to other epilepsy types and other conditions, for example in modeling
relapses in multiple sclerosis.

Public health relevance
Project Narrative Predicting epilepsy outcomes over time for a given patient is a significant challenge due to the large variability in the patient-specific course of disease. We propose to leverage our access to data from the Human Epilepsy Project, a large observational study of 450 patients with focal epilepsy, to develop novel prediction models for seizure trajectories that address substantial variability and clumping in seizure frequency. This work will assistant patients and clinicians identify optimal treatment earlier; for instance, this could help limit the amount of time patients are receiving ineffective medication and improve time to epilepsy surgical evaluation when indicated.